The Development of Emotion Regulation Mechanisms Impacting Health

DESCRIPTION (provided by applicant): In today's world, keeping healthy is not easy. On one hand, the challenges and uncertainties of our daily lives can take a toll, generating stress and susceptibilities to anxiety and depression that in turn contribute to chronic bodily ailments ranging from heart disease to diabetes. On the other hand, we are faced with opportunities for immediate gratification through eating tasty but unhealthy food, or consuming alcohol, cigarettes or controlled substances. Whether one acts in these ways as an antidote to feeling bad, or because they are pleasurable in their own right, a short-term gain can become a long-term pain when over time weight control, substance abuse or other related health problems develop. What can be done to change these unhealthy behaviors? To address this question, this application takes an interdisciplinary approach that combines the theories and methods of social, cognitive and affective neuroscience with the theories and methods of social and developmental psychology. The over-arching goal is to understand the development of the neural mechanisms that enable us to regulate the appetitive pull of potentially unhealthy substances (e.g. fattening foods or drugs) and the aversive push of unpleasant emotions that might motivate one to seek these substances in the first place. Our focus is on the development of these mechanisms from late childhood through adolescence - time periods critical for the development of these self-regulatory abilities and the maturation of the prefrontal-subcortical interactions underlying them. Our premise is that unless we understand the boundary conditions and underlying mechanisms for normal development of emotion regulatory abilities, it will not be possible to tailor future interventions appropriately - particularly for the age ranges and individuals for whom it could make the biggest difference. Towards this end, our application has two specific aims: Aim 1 - To chart the developmental trajectory of emotion regulatory mechanisms that support behavior change through childhood and adolescence; and Aim 2 - To relate the behavioral, physiological and neural measures collected under Aim 1 to measures of health and health behaviors, including BMI and substance use. To achieve these aims we will bridge two largely separate research literatures. The first uses an ecologically valid delay of gratification task for which childhood performance predicts adult health outcomes like BMI and substance use. The second uses brain imaging to identify the neural bases of the attentional control and reappraisal strategies used to delay gratification and regulate affective impulses more generally. Combining these methods with assessments of disordered eating, BMI, and substance use will allow us to test novel hypotheses about the basic mechanisms of behavior change, including how it may depend on a core set of prefrontal-subcortical interactions that mature during adolescence, and how patterns of individual and developmental variation in subcortically-driven affective reactivity and prefrontal control abilities may indicate which individuals are at greatest risk for maladaptive health behaviors.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is growing evidence that childhood and adolescence are critical times for development of the emotion regulatory abilities needed to adaptively balance affective impulses and the deleterious health behaviors they can promote. Using a combination of behavioral and functional imaging methods, this application aims to chart the development of the emotion regulatory mechanisms that enable us to rein in affective impulses and to relate these mechanisms to measures of the maladaptive health behaviors they can promote. The ultimate goal is to specify which individuals are at greatest risk for maladaptive health behaviors, at what age this risk is greatest, and which self-regulatory mechanisms could be targeted in future interventions (e.g. CBT) during particular points in the developmental course. Program Director/Principal Investigator (Last, First, Middle): There is growing evidence that childhood and adolescence are critical times for development of the emotion regulatory abilities needed to adaptively balance affective impulses and the deleterious health behaviors they can promote. Using a combination of behavioral and functional imaging methods, this proposal aims to chart the development of the emotion regulatory mechanisms that enable us to rein in affective impulses and to relate these mechanisms to measures of the maladaptive health behaviors they can promote. The ultimate goal is to specify which individuals are at greatest risk for maladaptive health behaviors, at what age this risk is greatest, and which self-regulatory mechanisms could be targeted in future interventions (e.g. CBT) during particular points in the developmental course. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page __SpecificAimsTextDelimiter__ Program Director/Principal Investigator (Last, First, Middle): 1. SPECIFIC AIMS In today's world, keeping healthy isn't easy. On one hand, the challenges and uncertainties of our daily lives can take a toll, generating stress and susceptibilities to anxiety and depression that in turn contribute to chronic bodily ailments ranging from heart disease to diabetes1-3. On the other hand, we are faced with opportunities for immediate gratification through eating tasty but unhealthy food, or consuming alcohol, cigarettes or controlled substances. Whether one acts in these ways as an antidote to feeling bad, or because they are pleasurable in their own right, a short-term gain can become a long-term pain when over time weight control, substance abuse or other related health problems develop4. What can be done to change these unhealthy behaviors? To address this question, this proposal responds directly to the FOA's call for social, cognitive and affective neuroscience approaches to understanding development of the neural mechanisms that enable us to regulate the appetitive pull of potentially unhealthy substances (e.g. fattening foods or drugs) and the aversive push of unpleasant emotions that might motivate one to seek these substances in the first place5. For two reasons we will focus on mapping the development of these mechanisms from late childhood through adolescence. First, while it is increasingly clear that early appearing affect regulatory abilities have important long-term implications for mental and physical health, the mechanisms mediating the link between the two are unclear6-13. Second, neuroscience research shows that the adult ability to regulate affective impulses depends on prefrontal and subcortical systems that begin to mature during adolescence14-26. These and other data indicate that late childhood and adolescence are critical times for developing emotion regulatory skills that can buffer one against health-relevant stressors and temptations throughout life. Despite this, scant research has examined the development of the neural systems mediating emotion regulatory abilities and their relationship to health outcomes. Given the evident theoretical and translational importance of this gap in knowledge, the proposed work aims to close it by characterizing the developmental trajectory of emotion-regulatory mechanisms supporting health-relevant behavior change from childhood through young adulthood so that those with poor regulatory ability - who are therefore at greater risk for maladaptive health choices and outcomes - can be identified. Aim 1: To chart the developmental trajectory of emotion regulatory mechanisms that support behavior change through childhood and adolescence Our first Aim will bridge two largely separate research literatures to deepen our understanding of emotion regulatory mechanisms. The first concerns the delay of gratification (DoG) task, where a child can have a small treat immediately or a larger treat if they can wait. Delay ability buffers against the development of high BMI, substance use, and emotional and social instability11, 27 up to 40 years later6 and improves when children direct attention away from treats or reappraise them as less desirable28, 29. The DoG task, however, can not reveal the neural dynamics that make this possible. The second literature does exactly that. Imaging studies of the Affective go/no-go (AGNG) task, where attention is used to ignore task-irrelevant affective properties of stimuli, and the Affective Reappraisal (ARPL) task, where one reinterprets affective stimuli in unemotional ways30, 31, show that the cognitive regulation of emotion depends on the use of prefrontal (PFC) control systems to modulate activity in subcortical systems that trigger affective impulses (e.g. amygdala and ventral striatum). How development of these neural systems supports maturing emotion regulatory abilities is largely unknown. To close these gaps in knowledge we will chart the development of performance on the DoG, AGNG and ARPL tasks, and the neural bases of the latter two tasks, using a cross-lag design that samples individuals ages 6-18 and again 2-3 years later. This will enable us to test novel hypotheses about the basic mechanisms of behavior change, including how emotion regulation abilities may depend on a core set of PFC control systems whose structure and connectivity with subcortical systems increases with age, but whose efficacy may vary across tasks/strategies, appetitive/aversive emotions, and pubertal stages15 with potentially non-linear changes in affective responsivity23, 32, 33. Supporting data is reported in section C1, Preliminary Studies. Aim 2: To relate the behavioral, physiological and neural measures collected under Aim 1 to measures of health and health behaviors, including BMI and substance use. Our second aim is to document relationships between the function of emotion regulatory mechanisms and health outcomes within the age range and across the time period we are sampling. To do this, we will assess BMI, eating and dietary habits, and substance use, including alcohol and tobacco, which have significant base rates among the typically developing population we will study34-36. We will test the hypotheses that the measures of emotion regulation collected under Aim 1 will (1) predict BMI and substance use better than measures of "cold" cognitive abilities, (2) will provide diagnostic signatures of good or poor regulation (e.g. good task performance, PFC activation, subcortical modulation, and connectivity between the two) at the individual and/or group levels that mark an individual as resistant or potentially vulnerable to maladaptive health outcomes (e.g. high BMI, substance use), and (3) that this vulnerability may be exacerbated by individual differences in temperament, impulsivity and mood37-41. Supporting data is reported in sections A, Significance and C1, Preliminary Studies. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page